Glutide for Ending Methamphetamine

Project Summary/Abstract
Methamphetamine use and toxicity has increased substantially over the past decade, with deaths attributed to
methamphetamine toxicity, largely consisting of cardiovascular complications, increasing 9-fold from 2012-
2021. There remains no FDA-approved medication to treat methamphetamine use disorder (MeUD),
notwithstanding decades of efforts. Moreover, most experts now feel that a combination of agents will be
required to effectively treat MeUD, addressing multiple neurotransmitter systems simultaneously. While many
agents that have shown promise are anti-depressant medications, GLP-1 agents have significant potential
promise and an entirely distinct mechanism of action. GLP-1 agonists, and semaglutide in particular, have
demonstrated a marked ability to reduce craving for people with substance use disorders. Craving is a major
component of MeUD and reducing this component may have a significant impact on methamphetamine use.
Some concerns exist in the use of GLP-1 agonists in this population, most notably the weight loss induced by
GLP-1 agonists, given the fact that some people with MeUD are significantly underweight. However, this
weight loss may be a benefit for the substantial proportion of people with MeUD whose methamphetamine use
is at least partially driven by weight loss or weight control benefits. Abstention from methamphetamine use is
associated with substantial weight gain, which may be prevented by GLP-1 agonist treatment. We propose a
two-phase study of semaglutide for MeUD. In the first phase, we will conduct an open-label single-arm Phase
IIa trial of semaglutide for MeUD. If the eligible:enrollment ratio, medication adherence, and willingness to
continue therapy meet prespecified levels, and there is evidence of reduced methamphetamine use, we will
proceed to a Phase IIb placebo-controlled randomized trial of semaglutide versus placebo to determine the
efficacy of this medication in achieving a clinically-meaningful reduction in methamphetamine use. These
studies will be done under FDA IND, in order to allow for potential future studies that could lead to a new
indication for semaglutide as the first medication approved for MeUD.

Public health relevance
Project Narrative There is no FDA approved medication for methamphetamine use disorder. GLP-1 agonists, and semaglutide in particular, show significant promise for addressing craving and use of methamphetamine. This project will conduct a pilot single-arm open-label trial of weekly injected semaglutide. If Go/No-Go criteria, including feasibility and preliminary efficacy, are met, a Phase IIb placebo-controlled randomized controlled trial of semaglutide will be conducted at two sites to improve generalizability. Results will contribute to potential development of semaglutide as a future FDA-approved treatment for methamphetamine use disorder.